Simultaneous high-throughput functional, transcriptomic and connectivity profiling using FUNseq

Project Summary
Recent advances in technology driven by the BRAIN Initiative have yielded new methods for characterizing the ac-
tivity, transcriptome, and microscale anatomy of neurons throughout the brain, and have increased the throughput
of these techniques by orders of magnitude. It is currently possible to record the simultaneous activity of popu-
lations of neurons on the order of tens of thousands of neurons in awake behaving animals in vivo using large
ﬁeld of view multiphoton imaging or high density silicon probes, and new machine learning methods are enabling
more comprehensive functional characterization than ever before. Transcriptomic proﬁling can be accomplished
at scales of tens or hundreds of thousands of neurons in vitro. Finally the microscale anatomy of axonal pro-
jections and connections across the brain can also be assessed in tens of thousands of neurons in the same
animal using dense electron microscopy reconstruction for local circuits, or (as we propose here) RNA barcoding
methods for local and long-range axonal projections. Each of these techniques on their own can provide im-
portant clues about the diversity of neurons and their organization into canonical circuits with speciﬁc functional,
transcriptomic, or axonal projection proﬁles. While these techniques are all being pushed forward independently,
they remain effectively siloed from each other, precluding multi-modal characterization of the same neurons in
the same animal. Developing a comprehensive pipeline to characterize transcriptomic, axonal projections and in
vivo functional ﬁngerprints as we propose to do here would enable synergistic analyses of cell-type composition
across these multiple dimensions. Finally, because of the low cost and high throughput of this approach, experi-
ments using this novel pipeline could be repeated many times in different animals to answer pressing questions
about how the relationship between the function, structure, and transcriptome of neurons changes across devel-
opmental or disease states. In this proposal, we will leverage our team's combined expertise in in vivo functional
imaging and Machine Learning to characterize the complex functional properties of neurons in primary visual
cortex of the mouse, and novel sequencing techniques developed by PI Zador to combine transcriptomic proﬁling
with RNA barcoding to measure single-neuron projection patterns throughout the brain at axonal resolution.

Public health relevance
Project Narrative There are many different types of neurons in the brain that perform different functions, and these cells are in- terconnected in speciﬁc circuits that support cognition and complex behaviors. Recently, neuroscientists have developed new, powerful tools to measure and characterize the activity patterns, genetic composition, and mi- croscale anatomy of individual neurons, but we do not at present have a good way to combine these techniques together in the same cells. In this proposal we develop a new pipeline that will yield a multimodal view of the function, structure, and genetic composition of huge numbers of neurons in the same animal, making it possible to identify different classes of neurons with important roles in behavior and cognition that may be disrupted in psychiatric disease states.